DEVELOPMENT FUNDS

Developmental funds provide the Center the ability to support strategic initiatives, take risks, strengthen scientific areas, and provide investigators the opportunity to explore innovative ideas, collaborations, technologies. The funds represent the foundation for growth and development. Developmental funds are administered centrally and targeted towards specific objectives determined during our planning and evaluation activities. The Director commits these funds for 1) start-up support for new faculty, 2) pilot projects, and for 3) developing Shared Resource facilities to provide promising opportunities for significant contributions to the science of the Center.